Core D- Administrative Core

Core D (Administrative Core) -­ Abstract/Summary.
The Administrative Core (Core D) will be responsible for the overall administration of the P01 program. It will
provide clerical support, meeting organization, data management and planning/evaluation services to this
Program. The responsibilities of Core D include the following aims: (1) Monitoring research progress in the P01
program via monthly scientific meetings and quarterly progress updates;? (2) Providing scientific oversight and
research direction both from the Core D leader, Dr. DePinho, and also from the experienced membership of this
program’s Scientific Advisory Board;? (3) Fostering communication and collaboration between P01 program
participants by facilitating meetings (in person and via the internet), managing an annual program retreat, and
maintaining a website for program data sharing and communication;? (4) Providing fiscal oversight and resource
allocation including the review of accounting summaries to ensure fiscal management, enabling subcontracts,
and establishing cost centers and reporting practices;? and (5) Facilitating data and reagent sharing and
dissemination to the research community.

Public health relevance
Narrative – Core D (Administrative Core) The Administrative Core (Core D) will be responsible for the overall administration of this P01 program. It will provide clerical support, meeting organization, data management and planning/evaluation services to enable effective research into PDAC biology and genetics for the purpose of informing on clinical treatment and outcomes.